TGF-beta Regulation of Mucosal and Systemic T Cell Immunity and Tolerance

Our research interest is to elucidate mechanisms of TGF-beta regulation of mucosal and systemic T cell immunity and tolerance, in order to offer targets to manipulate T cell immunity versus tolerance in animal models to develop potential therapies for relevant human diseases such as autoimmunity, cancer and infectious diseases. Specifically we would like to understand (1) how TGF-beta is involved in the function and development of CD4+CD25+ T regulatory cells (Treg) in mucosal and other lymphoid tissues, (2) how TGF-beta regulates T programmed cell death and the consequent immune tolerance, (3) how TGF-beta signal transduction and TGF-beta production in mucosal T cells are regulated, and (4) The cellular and molecular mechanisms of TGF-beta regulation of oral mucosal intraepithelial lymphocytes (IELs). Recently, we have focused on the isolation and characterization of CD4+CD25+ T regulatory cells from normal and genetically engineered mice and dissected the involvement of TGF-beta in immunosuppression mediated by T regulatory cells. Importantly, we have also identified that TGF-beta is a critical factor in the conversion of naive CD4+CD25- peripheral T cells to CD4+CD25+ T regulatory cells through induction of Foxp3, a master gene for T regulatory cell development. This finding not only has significant impact on understanding the generation of CD4+CD25+ regulatory T cells, but also makes it possible for the first time to design strategies to embellish the limited and/or inadequate numbers of T regulatory cells in the periphery, as needed, for therapeutic intervention in autoimmune diseases and inflammation. In addition, with the T-cell specific conditional TGF-beta receptor I knockout mice, we have shown that TGF-beta signaling is also critical for the development and generation of natural Foxp3+ Tregs in the thymus. In related studies, we have demonstrated that combination of clearance of apoptotic T cells by macrophages and immature dendritic cells with administration of autoantigenic peptide leads to generation of antigen-specific Tregs that in turn suppress autoimmunity and induce long-term immune tolerance. importantly, we have discovered that CCR8+ Tregs play a key role in the protection and maintenance of normal pregnancy in human being. Furthermore, we have also discovered that D-mannose induces Treg cells and suppresses type I diabetes and lung inflammation in mouse models. Moreover, we have discovered two transcription factors DBP and E2F8 play an opposite functions in the differentiation of anti-tumor Th9 cells. We have also revealed that TGF-beta uncouples glycolysis and inflammation in macrophages and controls the survival during sepsis. In addition, we have discovered that Activin A activation of Smad3 mitigates innate inflammation in mouse models of psoriasis and sepsis. Our immediate next steps are to decipher the molecular pathway(s) by which TGF-beta induces Foxp3 expression to define how CD4+CD25+ T cells are developed in and out of mucosal lymphoid systems, as well as to begin to resolve the mystery of TGF-beta's role in T regulatory cell mediated immune tolerance. We also intend to apply the knowledge obtained from our basic research in animal models to develop potential therapy for relevant human diseases including inflammation/autoimmune diseases, cancer and infectious diseases, with special attention to NIDCR mission relevant diseases such as wound healing, oral cavity associated inflammation and oral cancer.